Immune Tolerance in Non-Clonal Immune Systems

Immunological tolerance regulates unwanted responses of B and T cells to self-tissue, reducing the chances of autoimmunity and focusing the immune response on foreign antigens. We review our progress in using transgenic models expressing superAgs that promote either central or peripheral B cell tolerance to study the genetics of the processes. We identified and verified a number of candidate genes whose mutation allowed B cell escape. We propose to find additional candidates, and evaluate existing validated targets in greater depth. To expand the identification of new candidate genes, we will focus on use of CRISPR mediated mutation or knockdown in hematopoietic stem cells. For the detailed mechanistic studies, we will examine in more detail proteins involved in ER stress and oncogenesis. The long-term goal of these studies is to develop a comprehensive understanding of all of the genetic components maintaining immune tolerance at these stages. This knowledge should facilitate treatment of autoimmune disorders and impact vaccine development.

Public health relevance
Mice expressing superantigens to B cell receptors reveal tolerance checkpoints in a normal immune system. We have exploited this selection to identify mutations that promote escape with the goal of understanding how autoreactive B cells are regulated. The proposed studies aim to characterize how the genes of interest contribute to tolerance and how their mutation facilitates escape of potentially harmful self-reactive B cells.